The Biostatistics Research Center for the Impaired Awareness of Hypoglycemia Consortium

ABSTRACT
Individuals with Type 1 Diabetes (T1D) are susceptible to repeated episodes of hypoglycemia, which can result
in impaired awareness of hypoglycemia (IAH). As a consequence, IAH contributes to diminished recognition of
the need for external glucose and the blunting of counter-regulatory responses that are required to increase
blood glucose. This can be a very risky situation for T1D individuals with IAH, possibly leading to coma and in
some circumstances, death. This can be a very risky situation for T1D individuals with IAH, possibly leading to
coma and in some circumstances, death. Many T1D studies exclude IAH individuals because of confounding
issues. Therefore, the National Institute for Diabetes and Digestive and Kidney Diseases (NIDKK) has issued
two RFAs to form the IAH Consortium that will investigate factors which contribute to the heterogeneity of
restoration of awareness of hypoglycemia in adult T1D individuals with IAH. RFA-DK-21-020 and RFA-DK-21-
036 request applications for Clinical Centers and the sole Biostatistics Research Center (BRC), respectively.
The objectives of the IAH Consortium will be to
• determine if the most up-to-date management strategies using diabetes technology to optimize HbA1c
while minimizing hypoglycemia can restore awareness of hypoglycemia and improve counter-regulatory
responses in individuals with T1D and IAH
• identify the magnitude and duration of time in range, time spent in hypoglycemia or other metrics for
continuous glucose monitors that are associated with restoration of awareness of hypoglycemia
• determine the association of current or newly developed self-reported measures of IAH with counter-
regulatory responses to elucidate the heterogeneity in restoration of hypoglycemia awareness
The Department of Public Health Sciences at The Pennsylvania State University College of Medicine proposes
to serve as the BRC for the IAH Consortium, and will pursue seven specific aims.
Specific Aim 1: Collaborate on the development and conduct of studies, and lead statistical analyses
Specific Aim 2: Lead the Consortium in developing measures of self-reported IAH
Specific Aim 3: House a Central Laboratory
Specific Aim 4: Lead the Consortium in stakeholder engagement
Specific Aim 5: Develop data management and website processes
Specific Aim 6: Maintain regulatory compliance
Specific Aim 7: Provide communication and project management support

Public health relevance
PROJECT NARRATIVE Individuals with Type 1 Diabetes (T1D) are susceptible to repeated episodes of hypoglycemia, which can result in impaired awareness of hypoglycemia (IAH). As a consequence, IAH contributes to diminished recognition of the need for external glucose. This can be a very risky situation for T1D individuals with IAH, possibly leading to coma and in some circumstances, death. The NIDDK is forming the IAH Consortium, which will conduct studies to determine if the most up-to-date management strategies using diabetes technology will restore awareness of hypoglycemia.